Characterization of E. coli-specific T cells in Crohn's disease

PROJECT SUMMARY/ABSTRACT
Several lines of evidence have implicated T cells in the pathogenesis of Crohn's disease, an uncontrolled
inflammatory condition of the intestines in which immune cells overreact to the bacteria that live there.
Previous studies of antigen-nonspecific T cells in Crohn's disease have not identified overall differences in
them that would explain this over reactivity. However, we have recently identified CD4 T cells of the immune
system that can react to a peptide from protein antigen (OmpC) made by one such bacteria (E. coli), to which
antibodies are commonly seen only in people with Crohn's disease. We found that these OmpC-specific cells
make IL-10 unless they come from Crohn's disease patients, and hypothesize that this defect plays a central
role in the inflammation of Crohn's disease. IL-10 is a cytokine that clearly plays a central role in limiting
inflammation in the intestines, because mice without the IL-10 gene and humans born with a mutation in the
receptor for IL-10 both quickly develop severe enterocolitis, resembling Crohn's disease. The overall goal of
the studies proposed here is to determine why these gut flora antigen-specific T cells fail to make IL-10 in
Crohn's disease, as a mechanism by which tolerance to gut flora is lost in this condition. The novel approach
is to integrate single cell gene expression and epigenetic analyses in these OmpC-specific T cells we can
isolate with MHC-II tetramers. The hypothesis will be addressed in two Specific Aims with genome-wide
expression differences correlated with IL-10 expression in Aim 1, and an epigenetic basis for failed IL-10
expression in Crohn's disease to be revealed in Aim 2. Together these studies will advance our understanding
of abnormal IL-10 regulation by gut microbial antigen-specific T cells in Crohn's disease, and provide the
foundation for determining how such a defect contributes to disease pathogenesis.

Public health relevance
PROJECT NARRATIVE Crohn's disease is believed to represent an uncontrolled inflammatory reaction in the intestines to the bacteria that live there. We have recently identified T cells of the immune system that can react to one such bacteria (E. coli), and found that they normally make an anti-inflammatory factor (IL-10), but fail to do so in Crohn's disease. This project will reveal what makes these T cells behave differently in Crohn's disease, and thus tell us how Crohn's disease happens.